FEEDBACK ACTIONS OF TESTOSTERONE ON LH RELEASE IN MEN

The investigators will test the hypothesis that pulsatile testosterone delivery that emulates physiologically episodic secretion of androgen will inhibit LH and FSH release to a greater extent than continuous infusion of the same mass of testosterone over 24 hours in men with blocked Leydig-cell androgen biosynthesis.